Investigating the function of RBC-TLR7 in Sepsis

Project Summary/Abstract: Sepsis, the dysregulated host response to infection, is a leading cause
of death in the United States and accounts for one-fifth of all deaths globally. A comprehensive
mechanistic understanding of the host response during sepsis is imperative because the aberrant host
response rather than the pathogen itself drives organ failure and mortality. One fundamental and critical
knowledge gap is an understanding of how circulating red blood cells (RBCs) contribute to the abnormal
immune response. This project aims to deepen our understanding of the host response in sepsis by
focusing on the role of RBCs in regulating the inflammatory response to nucleic acids. This study
investigates the hypothesis that RBCs, through the expression of Toll-Like Receptor 7 (TLR7), actively
participate in immune responses during sepsis by regulating host derived RNA. Our preliminary data
indicate that both human and murine RBCs express TLR7 and can bind single-stranded RNA through
TLR7, that host derived RNA is increased on RBCs during sepsis, and that RBCs act as a trap for cell-
free RNA, dampening the immune response. Based on these findings, we propose the following aims
using human RBC samples from critically ill patients with sepsis, synthetic RNAs, and erythroid-specific
genetically deficient mice. In specific aim 1, we will establish the subcellular localization of TLR7 in
human RBCs and determine the RNA-sequestration capabilities of RBC-TLR7 during sepsis. RBC-
TLR7 expression during sepsis will be compared with healthy subjects. Lastly, we will perform miRNA
profiling and whole-genome sequencing of RNA associated with RBCs during sepsis. In aim 2, we will
determine the role of RBC-TLR7 in delivering RNA to immune cells. In aim 3, we will employ novel
erythroid tlr7 deficient mice to define the erythroid-specific functions of TLR7 in vivo using models of
polymicrobial sepsis and reductionist models of TLR-induced inflammation. Knowledge derived from
these studies will elucidate novel mechanisms of immune dysregulation in sepsis and serve as the
foundation for studying RBC immune function, potentially bridging a significant gap in our current
understanding of the host immune response.

Public health relevance
Project Relevance Far from inert, RBCs perform many functions beyond carrying oxygen. One such function is sequestering nucleic acids from the circulation. The goal of this study is to determine if RBC- nucleic acid scavenging contributes to the abnormal immune response observed in sepsis.